Kinase Control of Synergistic Cell Migration Mechanics

Project Abstract
Cell migration is a fundamental cellular process necessary for development and coopted in diseases like
cancer metastasis. Our long-term goal is to elucidate the signals that control migration and cancer invasion, so
that treatment strategies to reduce pathological migration and cancer metastasis can be improved. Fluctuations
in cell migration forces control leading edge protrusion-retraction cycles, but we do not know what controls the
force fluctuations. The overall objective here is to understand the signaling mechanisms that control and integrate
the fluctuating molecular forces of cell migration. Signaling pathways can act by directing spatially-localized and
coordinated fluctuations in actin, adhesion, and membrane tension paramters (instructive). Alternatively,
signaling pathways may instruct some processes and act without spatiotemporal precision (permissive) in others.
We will elucidate the cell migration control mechanisms by dissecting the temporal and spatial regulation of the
protein kinase ERK and its signaling outputs in untransformed and cancer cells. ERK acts on multiple steps in
the protrusion-retraction cycle. The disease-relevant cancer cells model a high-activity state, in which ERK
activity is upregulated due to onocogenic mutations. Our central hypothesis is that ERK instructs spatially-
localized synergistic fluctuations in actin assembly, adhesion lifetime, and membrane tension for edge motion
and cell migration. For the first aim, we will measure the temporal fluctuations in ERK activity during edge
protrusion and retraction using modified ERK biosensors. We will incorporate the experimentally-observed
activity fluctuations into a computational model and experimental tests to determine which patterns dictate
protrusion velocity and persistence. For the second aim, we will determine if spatiatially-organized ERK activity
controls edge motion. We will test membrane and adhesion-activated ERK for the ability to induce protrusion
experimentally and computationally. We will also test how the pattern of ERK retention in the membrane and
adhesion domains contributes to protrusion power and width. For the third aim, we will test if ERK is controls
membrane tension and adhesion lifetime for protrusion velocity. We will test signaling through Zyxin and Ezrin
to actin as possible mechanisms by which ERK controls these additional for molecular forces. The proposed
research is conceptually innovative because it tests the role of fluctuating ERK signals in the regulation of cell
migration. It is technically innovative in the development and use of new optogenetics tools and computational
models. The research is significant because it has the potential to reveal a new principle about how molecular
forces are integrated to bring about motion. It will also identify scaffolds and signals that control local ERK activity
fluctuations that could be adapted for new therapeutic strategies to control cell adhesion and migration.

Public health relevance
Project Narrative The proposed basic research is relevant to public health because it focuses on a fundamental cell process that is critical to development and wound healing and contributes to cancer metastasis. The work will lay the foundation for the development of new strategies to prevent and treat cancer metastasis.